Study of HIV Infection in the Etiology of Lung Disease (SHIELD) AIR: Air Pollution Impact on Respiratory Health in HIV

Combination antiretroviral therapy has dramatically improved survival for persons living with HIV (PLWH). With
increased life expectancy, PLWH now face significant morbidity from age-related comorbidities, including greater
prevalence of chronic respiratory diseases and accelerated decline in lung function. Lung injury is caused and
perpetuated by noxious particles, including cigarette smoke and air pollution. Air pollution, including fine
particulate matter (PM2.5) and nitrogen dioxide (NO2), has been shown to elicit inflammatory and oxidative stress
responses, and is linked to impairment in lung function, development of chronic lung disease, and respiratory
hospitalizations. While HIV is hypothesized to increase susceptibility to cigarette smoke, whether this extends to
other pollutants remains unknown, as is the contribution of pollution to the risk for lung disease among PLWH.
The Study of HIV Infection in the Etiology of Lung Disease (SHIELD) is an ongoing, prospective cohort of over
2600 individuals with or at-risk for HIV that has made significant contributions to our understanding of HIV-
associated lung function impairment and respiratory morbidity. SHIELD has demonstrated that HIV leads to
unique physiologic changes in the lung, including increased risk for airflow obstruction and deficiencies in gas
exchange, accelerated decline in lung function, and increased respiratory morbidity. However, the contribution
of environmental exposures to excess respiratory morbidity among PLWH is unknown. To address this gap, we
propose to extend SHIELD to address our overarching hypothesis that PLWH represent a population that
is uniquely susceptible to the health effects of air pollution and that pollutant exposure contributes to
the excess lung function impairment and respiratory morbidity among PLWH. Three independent but
complementary aims build upon the long-standing experience of the SHIELD cohort and add the expertise of
investigators in studying health effects of outdoor and household air pollution in vulnerable populations. Aim 1
will define the impact of outdoor air pollution exposure to both acute and chronic respiratory morbidity and lung
function decline among PLWH and comparable HIV-uninfected participants. Aim 2 will determine the association
between household air pollution and respiratory morbidity among PLWH. Aim 3 will characterize biologic
response to air pollution exposure, assessing whether HIV is associated with increased internal dose of exposure
and/or exaggerated oxidative host airway and systemic response. We will apply novel approaches through
molecular markers assessed with albumin adductome mass spectrometry. In all aims, we will examine how HIV
and markers of HIV control influence susceptibility to pollution. Successful completion of these aims will advance
our understanding of mechanisms and impact of air pollution in the setting of HIV. Further, our findings could
identify therapeutic targets among high-risk populations and guide development of interventions to improve
respiratory health and healthy aging among PLWH.

Public health relevance
The Study of HIV Infection in the Etiology of Lung Disease (SHIELD) is a prospective cohort of over 2600 individuals with or at-risk for HIV that has made significant contributions to our understanding that HIV infection is associated with increased respiratory morbidity and lung function impairment. Exposure to air pollution and increased susceptibility to air pollution may contribute to the excess respiratory morbidity among persons living with HIV (PLWH), and we propose to the extend the cohort in SHIELD AIR, which adds innovative approaches to outdoor and indoor air pollution assessment, comprehensive lung function measurement, and novel biomarkers of airway and internal response to exposure. Study findings will provide new insights into modifiable risk factors and targets for interventions aimed at improving lung health for PLWH.